GI262570 sodium tablets w/ metformin for 26 wks in NIDDM

To compare the effects of oral GI262570 in combination with metformin, to the effects of metformin alone on glycemic control (as measured by HbA1c) after 26 weeks of treatment.